Community-Engaged Approach to Supporting South Asians w/ Type 2 Diabetes at Risk for Depression

Community-Engaged Approach to Supporting Patients with Type 2 Diabetes at Risk for Depression
Background: Patients with Type 2 diabetes (T2D) are at increased risk for depression (60%), and patients
with depression have a 32% increased risk for T2D. The resulting comorbidity has significant implications for
disease burden, healthcare costs, and management of these disorders. In NYC, prevalence of diabetes ranges
from 7.1%-14.4%, and T2D patients are twice as likely to have symptoms of depression. This comorbidity is
more prevalent by sociodemographic characteristics such as sex, education level, income, and English
proficiency. Given significant barriers to accessing medical and mental healthcare services (e.g., affordability,
accessibility) there is an urgent need for interventions to comprehensively address this comorbidity. Building on
an innovative and successful community health worker (CHW)-led T2D intervention at NYU Grossman School
of Medicine (DREAM Initiative - R01DK11048), this K01 proposal will adapt this CHW-led T2D intervention to
include mental health and digital health components, and test the feasibility and acceptability of this
intervention to support participants with T2D who are at risk for depression. In this proposed pilot intervention,
CHWs will provide tailored health education to participants on management of T2D and depressive symptoms
using the DREAM intervention and adapted content from the WHO’s Group Problem Management+
psychological intervention program, and facilitate referrals to mental healthcare services. A CHW facilitated text
message discussion group will reinforce health messages between health education sessions, and a wearable
fitness tracker will be given to participants to monitor daily fitness and sleep patterns.
Specific Aims: 1) Examine factors associated with distress, poor mental health, and comorbid T2D and
depression among participants to inform pilot study structure and content; 2) Adapt CHW-led T2D intervention
to include mental health and digital health components using a trauma informed care approach and the
ecological validity model; and 3) Evaluate the feasibility and acceptability of a pilot CHW-led intervention to
support participants with T2D who are at risk for depression.
Training: The mentored training plan will include didactic and experiential learning opportunities. Primary
training topics will include clinical management of diabetes, clinical T2D research, trauma informed care,
mental health, digital health, and grant writing. The training will include formal coursework, workshops,
seminars, directed readings with mentors, and participation in mentor study meetings.

Public health relevance
PROJECT NARRATIVE T2D is high among South Asian Americans, and available data indicate that depression is high but mental health service utilization is low in this population. Building on an innovative and successful community health worker (CHW)-led T2D intervention (DREAM Initiative - R01DK11048), this K01 proposal will adapt this CHW- led T2D intervention to include mental health and digital health components, and test the feasibility and acceptability of this intervention to support South Asians with T2D who are at risk for depression. Findings from this pilot study will inform a future randomized controlled trial to assess for scalability and efficacy.